Functional Analysis of GWAS loci associated with hearing loss.

Hearing loss is a highly prevalent and debilitating neurosensory disorder associated with substantially reduced
quality of life and overall health. It currently affects 430 million people worldwide; by 2050 this is expected to
increase to nearly 2.5 billion and result 1 in 10 people requiring rehabilitation. About 50% of cases are predicted
to have a genetic basis, however hearing loss can also be caused by other factors such as age, ototoxic drugs,
noise, infection or injury. Low-cost next generation sequencing technologies have facilitated many genome-wide
association studies (GWAS) and exome sequencing projects that have identified hundreds of variants and genes
associated with hearing loss. There are currently more than 150 loci and over 100 genes associated with non-
syndromic hearing loss, however few candidate genes have been identified for complex phenotypes such as
age-related hearing loss (ARHL) or
presbycusis, which
is becoming increasingly common as the population
ages. A GWAS conducted to identify candidate genes associated with ARHL identified 44 independent genomic
loci associated with hearing loss. A nearest gene was mapped for each SNP identified in this study, yet how this
SNP influences gene function in hearing loss has not been determined. Establishing a linkage between the target
genes and the disease phenotype is a huge challenge that ultimately affects the correct diagnosis; generating
similar phenotypes upon gene inactivation in animal models can establish a strong support for a candidate gene.
We identified 39 orthologs of 44 GWAS candidate genes in zebrafish, and further selected 29 novel genes that
will be tested functionally for their role in hearing loss by (1) generating a library of zebrafish mutants for 29 (and
paralogs) candidate genes associated with ARHL (2) analyzing these mutants via a high-throughput phenotyping
pipeline including morphological, cellular, and behavioral phenotypes. Identifying the functional consequences
of the candidate genes in zebrafish will yield mechanistic insights in disease pathogenesis.

Public health relevance
Project Narrative Age-related hearing loss (ARHL) or presbycusis, which is becoming increasingly common as the population ages, and the genetic basis of ARHL is not well-defined, however, Genome-wide Association studies (GWAS) are rapidly identifying new variants and candidate genes. To understand their role in ARHL, we will generate knockouts of candidate disease genes associated with ARHL in zebrafish to determine the functional consequence of such mutations in ARHL. Identifying the functional consequences of causal variants involving ARHL will be crucial in understanding the molecular basis of the disease that will ultimately be required for the development of therapeutics.